RANDOMIZED TRIAL TO COMPARE THE EFFICACY AND SAFETY OF WELLFERON AND INTRON-A

The purpose of this study is to compare two different forms of interferon to see whether or not they are equally safe and effective in patients with chronic hepatitis C.